Regulation of Salmonella Virulence bythe PhoP Protein

PROJECT SUMMARY Pathogens harbor virulence genes, which are required to cause disease. Paradoxically, pathogens also harbor anti-virulence genes, which restrict virulence potential. Anti- virulence genes likely play roles in chronic infection and transmission to new hosts. Understanding the interplay between virulence and anti-virulence genes will define the full range of variables that directly impact the progression of disease. This proposal seeks such understanding by focusing on the mgtCBR virulence operon of the facultative intracellular pathogen Salmonella enterica serovar Typhimurium, which specifies the F1Fo ATP synthase inhibitor MgtC, the Mg2+ transporter MgtB, and the MgtR peptide that promotes MgtC degradation. Homologs of the mgtC and/or mgtB genes are required for virulence in important human pathogens, including Mycobacterium tuberculosis, Burkholderia cenocepacia, Brucella suis, Yersinia pestis, Pseudomonas aeruginosa, and S. enterica serovars Typhi and Typhimurium. We propose to investigate how novel genetic elements control the temporal display of virulence, and how Salmonella regulates an anti-virulence trait. Specifically, we will explore the biochemical function and physiological role of two novel genes that modify the levels, activities and/or availability of the MgtC and MgtB virulence proteins. In addition, we will seek to understand how the structural protein MgtC enhances the levels of active PhoP, the master regulator of Salmonella virulence and transcriptional activator of the mgtC gene. Finally, we will explore the mgtCBR-mediated physiological changes that promote tolerance to antibiotics. The proposed research will reveal new concepts in bacterial pathogenesis applicable to various organisms and disease conditions.

Public health relevance
PROJECT NARRATIVE Pathogens produce virulence factors that cause disease in susceptible hosts. This proposal examines how pathogens control the levels, activities and availability of their virulence factors.